Identification and characterization of novel transcribed ultraconserved regions as long non-coding RNAs in medulloblastoma

PROJECT SUMMARY/ABSTRACT
Medulloblastoma (MB) is the most common malignant pediatric brain tumor. MB accounts for over 60% of all
embryonal tumors in US children aged 0-19 with nearly 300 cases of this cerebellar tumor diagnosed in the US
per year. While the 5-year survival rate for pediatric MB patients is just over 70%, children who undergo standard
of care treatments frequently experience permanent neurological deficits such as reduced motor and cognitive
functions. Additionally, all medulloblastoma subgroups lack approved targeted therapies. This application
proposes to investigate in MB the role of “Transcribed Ultra-Conserved Regions” (TUCRs) about which there is
no published literature. TUCRs represent a distinct group of 481 transcripts that are 100% conserved across
human, mouse, and rat genomes. A large fraction of TUCRs likely consist of long non-coding RNAs. Since their
discovery, TUCRs have only been correlated to a handful of cancers and remain exceedingly underexamined
within cancer research. I performed the first analysis of TUCRs in MB. I performed differential gene expression
analysis of RNA-sequencing data from MB tumors and normal cerebellum samples and identified a multitude of
differentially expressed TUCRs. Using Kaplan-Meir survival analyses, I identified numerous TUCRs whose
expression was significantly correlated with overall survival. I generated a multifaceted, computational ranked
scoring and prioritization system, which identified the top TUCRs in MB. Utilizing well established MB human
cell lines and siRNA knockdown technology, I discovered top scoring TUCRs such as uc.242 and uc.115
significantly promote MB cell invasion. I propose to study the expression, functions and mechanisms of action
of TUCRs in three aims: Aim 1 will identify and prioritize dysregulated TUCRs in MB and its subgroups by
conducting analysis on tumors from two multi-institutional research programs. Completion of differential
expression analysis, survival analysis, and prioritization scoring as performed in the preliminary analysis will
produce the top TUCRs in MB. Aim 2 will determine the functional effects of the top four TUCRs in MB through
the implementation of in vitro cell proliferation, invasion, migration, and death assays and in vivo tumor
formation and survival analysis (Subaim 2.1). TUCR function and mechanisms will be investigated with WGCNA
on all TUCRs in MB (Subaim 2.2). Completion of this work will elucidate the oncogenic and tumor suppressive
nature of the top TUCRs in MB. Altogether, this proposal investigates the oncogenic and tumor suppressive
nature of TUCRs in MB. It represents the first study of TUCRs in MB and will significantly advance the basic
understanding of this highly understudied class of molecules. Not only is the proposed work impactful, innovative,
and feasible, it incorporates a strong training plan designed to significantly advance the investigator as a cancer
researcher. UVA provides a robust training environment with multiple experimental cores, accredited classes, and
renowned mentorship.

Public health relevance
PROJECT NARRATIVE Transcribed Ultraconserved Regions (TUCRS) are severely understudied molecules in cancer, and nothing is known about them in medulloblastoma (MB), the most common malignant pediatric brain tumor. There are no approved targeted therapeutics for MB and MB patients who under the current standard of care treatment frequently experience permanent neurological deficits that significantly reduce health related quality of life. I propose a first investigation of the dysregulation, functions and mechanisms of TUCRs in MB whose findings will lead to a better understanding of the molecular basis of MB and could uncover new therapeutic targets.